CK20-002 - Enabling Rapid and Accurate Identification of Emerging Vector-Borne and Zoonotic Threats in Indonesia

Project Abstract
Zoonoses account for at least 75% of emerging human diseases globally. Indonesia has
been identified as one of the major emerging pathogen “hotspots” and the
opportunities for an emergence event to become epidemic in the absence of a reliable
detection system across Indonesia are high. Through Detection and Characterization of
Emerging Vector-Borne and Zoonotic Pathogens in Indonesia project, we will recognize
and identify these events and to rapidly detect the transmission of pathogens with
pandemic potential to human populations in Indonesia. In our existing CK15-001, we
have established capacity at the Eijkman Institute for recognition and identification of
emerging pathogens and piloted the use of these technologies to detect the transmission
to human populations in Indonesia.
The work in this follow up proposal will lay the foundation for a network of trained
laboratory personnel, provide baseline information on the vector-borne agents likely to
emerge and cause human disease in the fourth most populated country in the world,
and rapidly characterize any vector-borne pathogen of human concern circulating in the
country. Completion of these aims will not only provide direct public health benefits to
Indonesia, but will aid in advancing the Global Health Security Agenda (GSHA)
objectives of understanding the risk to US populations by assessing emergence events
globally.

Public health relevance
Project Narrative The main objectives of this program are to ensure that a well-trained group of Indonesian researchers have the capacity to detect and characterize pathogens of potential human significance from clinical and environmental samples and to examine archival and prospective samples for the presence of human pathogens using a range of virological and molecular methodologies. This new research proposal is designed to build on programmatic elements that were implemented in the CK15-001 which will conclude 7/31/2020. With infrastructure, trained personnel, and primary equipment in place, we can now proceed to discover, diagnose, and characterize vector-borne and zoonotic pathogens; strategically conduct surveillance to establish the role of these pathogens in presentations of acute febrile illness (AFI); and investigate the transmission dynamics of vector-borne and zoonotic disease agents. By the end of Year 5 of this new cooperative agreement, we anticipate having significantly increased and broadened Indonesia’s capacity for molecular diagnosis of emerging vector-borne diseases. Specifically, we plan to have the ability to routinely carry out deep sequencing of selected AFI specimens, institute metagenomic testing, and establish routine testing for Rickettsia and arboviruses found in neighboring countries. We anticipate testing 1000-1500 samples per year collected from all regions of the country. Additionally, we plan to incorporate testing for several pathogens that cause symptoms similar to vector-borne agents and would be included in any differential diagnosis, including leptospirosis and hantavirus. Additional partners and studies will be incorporated in later years of this agreement (CK20-002) to incorporate areas with distinct ecologies and transmission potential as opportunities are identified and deemed appropriate to the goals of the program.